Studies of the KIAA0319L-mediated productive transduction pathways of rAAV vectors

PROJECT SUMMARY
Recombinant adeno-associated virus (rAAV) vector has emerged as one of the preferred gene delivery
vehicles in clinical gene therapy. To date, three rAAV-based drugs, Luxturna, Zolgensma, and Roctavian have
been approved by the US FDA for treatment of an inherited blindness (RPE65 deficient), spinal muscular
atrophy, and severe hemophilia A, respectively. In addition, over 250 clinical trials of human gene therapy
using rAAV vectors have been carried out or are ongoing and have yielded inspiring outcomes. However, there
remain many barriers from vector binding, entry, intracellular trafficking, nuclear import, to gene expression to
be resolved, in particular, the mechanism of the receptor-mediated entry and intracellular trafficking. Different
rAAV vectors use different glycans as the primary attachment receptors for vector binding and a proteinaceous
receptor for vector entry of cells. KIAA0319L, a type I transmembrane protein, has been identified as a multi-
serotype AAV receptor involved in transduction of rAAV1-3, 5, 6, 8, and 9. It directly binds to rAAV vector in
vitro, and an anti-KIAA0319L antibody or purified recombinant extracellular domains of KIAA0319L efficiently
block rAAV transduction. However, the physiological function of KIAA0319L remains elusive. We identified
KIAA0319L is both N- and O-glycosylated and is the bona fide 150-kDa AAV2 binding protein that has been
previously identified. Its glycosylation does not contribute to the binding and transduction of rAAV vectors.
Biochemically, unlike its closely related protein KIAA0319, KIAA0319L per se is not homodimerized, but likely
heterodimerized. Swapping of the KIAA0319L PDK2 domain to KIAA0319 confers KIAA0319 to mediate rAAV2
transduction at the same efficiency as KIAA0319L. Notably, KIAA0319 is endocytosed through a clathrin-
dependent endocytosis pathway in a homodimer format; however, KIAA0319L is dynamically recycled from the
plasma membrane to the trans-Golgi network (TGN). Therefore, we hypothesize that KIAA0319L interacts with
cellular membrane proteins to form a heterodimer that directs the endocytosis and intracellular trafficking of
rAAV towards the TGN retrograde transport pathway. This proposal is aimed at identifying the KIAA0319L-
heterodimerized partner(s), and the endocytic vesicles to the TGN pathway mediated by the heterodimer. Our
long-term goal is to identify steps that limit rAAV transduction and that can be altered, and, therefore, can be
used to enhance rAAV transduction. The basic characterization of the KIAA0319L protein is the first step on
the road towards understanding the role that KIAA0319L plays as a multi-serotype AAV receptor, and also to
determine the role of KIAA039L-interatcing protein(s) which may function as a co-receptor and mediate unique
tropism of different AAV capsids to cells and tissues.

Public health relevance
PROJECT NARRATIVE The proposed study will identify the cellular membrane protein(s) that interact with the KIAA0319L protein, the multi-serotype AAV receptor (AAVR), and will reveal the entry and intracellular trafficking pathways of rAAV that are led by the complex of AAVR and AAVR-interacting proteins (AAVR-IP), which will help increase the gene delivery efficiency using rAAV vectors in human gene therapy.